Mechanistic studies of chromatin modification in transcription regulation

PROJECT SUMMARY
Post-translational modifications of the histone proteins that package DNA play a central role in regulating
transcription and repair of DNA damage. The goal of this research program is to determine the molecular
mechanism by which attachment of the small protein, ubiquitin, to histone proteins functions in concert
with modifications including methylation and acetylation to regulate gene expression. Since misregulation
of histone ubiquitination and methylation characterizes many cancers, the results of these studies can be
used to design new drugs that target the molecular machines involved in these pathways. A major focus
will be on the mechanisms by which histone H2B-K120 monoubiquitination orchestrates multiple events
during transcription that result in gene activation. A multidisciplinary approach combining cryo-electron
microscopy, x-ray crystallography, solution biochemistry and cell-based approaches will be used to study
the mechanism by which ubiquitin is specifically attached to histone H2B during transcription and the
distinct mechanisms by which different deubiquitinating enzymes distinguish between H2B in intact
versus partially disassembled nucleosomes. We will also determine the nature of intra- and inter-
nucleosomal cross-talk between histone ubiquitination, methylation and acetylation mediated by
transcriptional activators that act downstream of H2B ubiquitination. Building upon the recent discovery
of first-in-class macrocyclic inhibitors of the human SAGA H2B deubiquitinating enzyme, we will
determine their mechanism of action and derive principles that will drive further drug discovery of multi-
subunit deubiquitinating enzymes. To elucidate the molecular basis by which H2B ubiquitination drives
cell proliferation in MLL-rearranged leukeumia, we will uncover the role of histone ubiquitination in
stimulating the activity of MLL1 fusion complexes that result from chromosomal rearrangements. The
molecular insights that will result from the proposed studies will provide a foundation for developing new
chemotherapies that target cancers for which there currently are no effective treatments.

Public health relevance
NARRATIVE Many tumor types are characterized by altered patterns chemical tags found on the histone proteins that package the human genome, leading to defects in gene regulation and DNA repair. Insights into the molecular mechanism by which cells attach and remove these tags, as well as how the tags regulate gene expression, can be used to devise new treatments. This research is being used to drive efforts to develop drugs to treat cancers that are resistant to current therapies.